Developing and Pilot Testing a Mental Health Support Intervention for Ethiopian and Eritrean Youth

PROJECT SUMMARY
Nearly one in five Black Americans are first- or second- generation immigrants; however, little research to date
focuses on the experiences of these communities in a disaggregated and/or culturally-specific fashion.
Emerging adults (ages 18-29) from Black immigrant backgrounds face multiple intersecting challenges to their
mental health, as they attempt to transition to adulthood and develop their identity, all while navigating
intergenerational traumas from the immigration process as well as ongoing racism and discrimination faced as
Black people in the United States. Our preliminary research has identified significant mental health disparities
impacting Ethiopian and Eritrean (collectively referred to as habesha) emerging adults in Atlanta. Despite these
threats to mental health and well-being, and the growing representation of habesha and other immigrant
groups within the larger Black population, there are no evidence-based interventions that have been developed
or tested specifically for Black immigrant emerging adults. Our long-term goal is to improve mental health
among habesha emerging adults, as a first step towards ameliorating disparities impacting Black immigrants
more broadly. The objective of this R21 application is to develop and pilot test Weyera, a novel group-level
intervention facilitated by trained community health workers, with a goal to enhance resilience and improve
mental health in this population. This study will pursue two specific aims: (1) To develop Weyera, a culturally-
responsive mental health support intervention for habesha emerging adults; and (2) To conduct a pilot trial of
Weyera and evaluate its feasibility, acceptability, and safety. For the first aim, we will use the Intervention
Mapping approach and work with our established Youth Advisory Board (comprised of habesha emerging
adults) to refine an intervention outline and develop objectives and activities through a participatory, iterative
process. In the second aim, we will pilot Weyera in a randomized waitlist control trial. Our evaluation will
primarily focus on feasibility, and acceptability and safety, while also exploring potential intervention impacts on
hypothesized effect modifiers (resilience processes: i.e., social support, affirming ethnic identity, mental health
service utilization) and mental health outcomes (depression, anxiety and trauma). We will assess our primary
and secondary outcomes using mixed methods including serial surveys as well as qualitative exit interviews,
and we will also conduct process evaluations to monitor fidelity and adoption. Results from this study will
provide the foundation for a larger efficacy trial of Weyera in the future. The proposed research is highly
significant because of its potential to begin to address the critical gap of knowledge and intervention focused
on habeshas or any Black immigrant group. Attention to understudied nuances including ethnicity, nativity and
immigration status within the Black population is critical to achieving the NIH’s overall goals of addressing the
impacts of racism and discrimination on health.

Public health relevance
PROJECT NARRATIVE The proposed project seeks to develop and pilot test a mental health support intervention (Weyera) to build resilience among Ethiopian and Eritrean emerging adults. This project is relevant to public health because Black immigrant-origin groups, including Ethiopian and Eritrean emerging adults, are a large and growing population who encounter significant mental health challenges that remain unaddressed.